ECHO Yakima Valley

ABSTRACT
ECHO Yakima Valley enriches the ECHO Program in two primary ways. 1) We will
increase representation of rural and agricultural communities in the national ECHO
Cohort so it may better support child health research across the range of American
communities. With deep research ties to Washington's Yakima Valley, our team is
poised to enroll over 1000 pregnant women into the ECHO Cohort through partnerships
with their prenatal and pediatric healthcare home. Biospecimen collection will be led by a
sub-team with experience establishing and directing a biorepository for over 10,000
pregnancies. 2) Our investigator team spans various career stages and specialties and
will implement an interdisciplinary approach to ECHO papers, incorporating insights from
environmental health science, biostatistics, epidemiology, and pediatric medicine. We
will apply our expertise to advance ECHO science to describe the relationships between
commonly encountered pollutants (including fine particulate matter, ozone, and nitrogen
dioxide) and major chronic pediatric health concerns, such as preterm birth, low
birthweight, respiratory infections, asthma development and exacerbation, obesity, blood
pressure, and neurodevelopment. We propose to lead a new ECHO-wide interest group
on Air Pollutants and Wildfire Smoke as well as an interest group to bring together
expertise in Rural Health. We will aim to develop new ECHO manuscripts to understand
child health risks related to mixtures of common air pollutants, pesticides, and drinking
water contaminants. We have plans for a set of novel preconception analyses
addressing contaminants of concern for drinking water wells, an underdeveloped topic
for ECHO. We also propose to expand ECHO Program data resources with advanced
models for estimating participant exposures to ultrafine particulate matter and wildfire
smoke. We plan to lead development of brief, low-burden extensions to the ECHO
Protocol to better characterize family knowledge of the Air Quality Index (AQI). These
data will allow ECHO scientists to explore opportunities to improve access to this public
health tool as well as evaluate its effectiveness in mitigating health effects. A proposed
novel Wildfire Rapid Response Protocol will enable natural experiment analyses of
wildfire related health crises nationwide. Overall, ECHO Yakima Valley will build on our
team's prior successes and insights we gained as the ECHO PATHWAYS multi-cohort
award center point for project coordination and team science. We will continue these
efforts in ECHO Cycle 2 with a focus on solution-oriented research that may efficiently
and directly inform public health policy and programs.

Public health relevance
Public Health Relevance Statement (new) NARRATIVE The ECHO Yakima Valley project will enrich the ECHO Cohort with participants from a rural, agricultural community. Research activities are designed to answer important questions regarding exposures of all children to common pollutants such as particulate matter, ozone, pesticides, and drinking water hazards. We will translate this research to efficiently inform US policy and programs. ECHO Yakima Valley will engage local organizations and bring multidisciplinary scientific expertise to the ECHO Program.